UNC Pelvic Floor Disorders Research Collaborative

Research focused on women's health at the University of North Carolina (UNC) is sophisticated and widespread with many committed investigators addressing issues of fundamental importance to women. UNC has a tradition of excellence in clinical care, training and research in pelvic floor disorders and includes one of the nation's first accredited fellowship programs in the Division of Urogynecology and Reconstructive Pelvic Surgery. We offer comprehensive evaluation and treatment options in a high-volume care setting that serves as a tertiary referral center for women from across the state. More than 2,000 women have sought care for pelvic floor disorders at UNC in the previous five years. Seventy-five percent are Caucasian and 22% are African American, predominantly from rural and suburban communities with stable care and follow-up patterns. Approximately 260 women have multi-channel urodynamic and fluoroscopic studies annually. Care providers have extensive expertise in both surgical and non-surgical management of urinary incontinence, pelvic organ prolapse and defecatory dysfunction. The Division of Urogynecology performs an average of 80 surgical procedures for the primary indication of urinary incontinence, 148 for prolapse and provides medical management for 137 women with these conditions each year. Both Urogynecology and Urology have recently added faculty which will further enhance clinical volume. The UNC Pelvic Floor Disorders Research Collaborative led by the Division of Urogynecology is pleased to submit this proposal to serve as a site in the Clinical Trials Network for Female Pelvic Floor Disorders. The Collaborative is a multidisciplinary team of outstanding investigators in tuogynecology, urology, gastroenterology, colorectal surgery, radiology, internal medicine, and clinical research methodologists. They have a history of strong clinical ties and dedication to interdisciplinary research. Diagnostic resources include multi-channel urodynamic testing, cystoscopy, defecography, pelvic MRI, 360-degree anal ultrasound, anal manometry and needle electromyography. Clinical services include surgical treatment of complex pelvic floor disorders and a wide range of non-surgical options including pelvic floor exercise programs with biofeedback, pessary management and behavioral and -pharmacologic therapies. A UNC network site will have access to research infrastructure with proven ability to support large-scale, multi-centered clinical research. The Collaborative is well-equipped and uniquely qualified to be an asset to the Clinical Trials Network. Given the exceptional quality of the research opportunities and resources available at UNC, the stable and diverse patient population, the strength of the investigator pool, the genuine willingness to collaborate and the commitment of the institution to the stated goals of this RFA, we look forward to making substantial contributions to advancing women's health in the area of pelvic floor disorders.